RADIOACTIVE MICROSPHERE MEASUREMENT SYSTEM

Regional blood flow measurement using radioactive microspheres is currently the only method available to measure the distribution of blood to very small organs (such as fetal endocrine glands) and the partition of blood supplied through a single main vessel to organs comprised of several tissues that can easily be separated physically e.g. muscle, fat and bone in a hindquarter. Each of the principal investigators is conducting studies that would be improved by the ability to measure regional blood flows under various conditions in the same animal. The radioactive microsphere measurement system requested will permit the measurement of flows on several occasions - up to 9 - in the same animal in different physiological situations (e.g. a wish to look at ovarian regional blood flow at different times in the reproductive cycle) and following different perturbations induced experimentally (e.g. hypoxia administered to the pregnant animal). Each of the principal investigators has several years of past funding from the National Institutes of Health and is well established in his field.